Neurologic Clinical Epidemiology Training Program

PROJECT SUMMARY
The Department of Neurology, including the Division of Child Neurology, and the Center for Clinical
Epidemiology and Biostatistics (CCEB) at the University of Pennsylvania propose to continue and enhance an
innovative, rigorous, and successful two- to three-year research training program for clinicians in both adult
and pediatric neurologic clinical epidemiology research.
The training program focuses on mentored research with an experienced investigator that involves didactic
training and the planning, design, conduct, analysis, and interpretation of an independent neurologic clinical
research project, all intended to be the next step in a trainee’s academic career preparing him/her for a career
as an independently funded researcher. Trainees matriculate in the Master of Science in Clinical
Epidemiology (MSCE) program. Didactic coursework consists of required courses in epidemiology and
biostatistics, the basic sciences of high-quality clinical research, methodology in neurologic clinical
epidemiology, advanced epidemiology, protocol development, sophisticated biostatistics, and elective courses
relevant to the trainees’ methodologic interests. The training program is enhanced by journal clubs and clinical
research conferences led by faculty; instruction in the responsible conduct of research; and a professional
development series. The program will: 1) train clinicians to be rigorous and independent academic
investigators able to use the range of approaches available in epidemiology to address research issues in
neurology; 2) provide closely mentored research experiences with faculty preceptors in clinical epidemiology
and neurologic medicine; and 3) strengthen the links between traditional epidemiology and neurology. The
program aims to recruit a diverse group of trainees and provide them with an inclusive and supportive
environment that enables them to reach their full potential.
Strengths of the proposed program are: 1) the long history of successful research training programs in adult
and pediatric neurology using the structure provided by the CCEB, including this training program; 2) the
collaborative links that have been forged among faculty with interests in clinical research in neurology; 3) the
comprehensive course offerings and research programs that are available to trainees; and 4) an extensive set
of experienced and multidisciplinary faculty mentors with successful training records. The training program also
brings together dozens of trainees from across all disciplines in medicine, which provides an ideal environment
for collaborative learning and growth. The program recognizes the importance of addressing issues of health
disparities and aims to train investigators who are equipped to address these challenges. Finally, The University
of Pennsylvania and the Perelman School of Medicine promote an academic environment in which basic,
clinical, and translational research are encouraged and viewed as attractive career paths for physicians.

Public health relevance
PROJECT NARRATIVE There is a national shortage of qualified clinician-scientists with the skills to conduct the rigorous clinical research needed to address the most vexing population-based questions in neurology. Leveraging the efforts of a distinguished, experienced, and committed training program faculty, a rigorous curriculum of both didactic training and mentored research, and a world-class biomedical research environment, this training program provides trainees with the skills needed to design, conduct, and complete high-quality epidemiologic research in clinical neurology.